Administrative Core

ADMINISTRATIVE CORE: ABSTRACT
Our inter-institutional U54 Serological Sciences Center of Excellence (“U54”) Administrative Core
provides scientific and administrative oversight for all of the U54’s Projects and Cores. It also provides the main
interface with patient advocates, NCI program staff, external and internal advisory boards, NCI SeroNet activities,
other Lung Cancer NCI Networks, and collaborating institutions. The Center’s Administrative Core is led by three
world leaders in lung cancer translational research, founders of the COVID-19 Lung Cancer Consortium (CLCC),
who all have extensive experience leading large and complex lung cancer translational research programs: Dr.
Fred R. Hirsch at the Tisch Cancer Institute and Icahn School of Medicine at Mount Sinai, Dr. John Minna at
UTSW and Dr. Paul A. Bunn Jr. at the University of Colorado. The Administration Core PIs will work closely with
the U54 overall Co-PI (Dr. Adolfo Garcia-Sastre), the U54’s Steering Committee, which consists of the overall
PIs, the Administrative Core PIs, the Project and Core PIs, and a representative for our partner organization, the
patient advocacy organization GO2 Foundation for Lung Cancer. The U54’s Steering Committee will have the
assistance and advice of an Internal Advisory Board (IAB) and an External Advisory Board (EAB). The IAB
will be established within the Mount Sinai Health System and will provide scientific advice and smooth access to
required institutional resources. The EAB consists of international leaders in thoracic oncology and in medical
virology and vaccinology and will assist with providing scientific advice and evaluating scientific progress with a
special focus on lung cancer implications. The specific aims of the Administrative Core are: AIM 1: Direct
the overall scientific integration and administrative management of the U54 and ensure effective communication
between U54 Project and Core investigators; AIM 2: Oversee Administration of Patient Cohorts, Clinical Studies,
Financial Reporting, and Regulatory Aspects; and AIM 3: Manage connection of the U54 with the NCI, SeroNet,
and other lung cancer research (e.g. NCI Lung-SPORE) and patient advocacy networks. Thus, the
Administrative Core will help this U54 to maximize its potential both internally (Mount Sinai, UTSW, and
University of Colorado), and inter-institutionally, including interactions with the NCI Serological Sciences Network
and the Frederick National Laboratory for Cancer Research (FNLCR).
Successful completion of our U54 activities is expected to substantially increase our understanding of the
association between lung cancer SARS-CoV-2 antibody response based on infection or vaccination, and
ultimately be of significant service in designing lung cancer patient-specific SARS-CoV-2 preventive measures.